Enrichment Program

PROJECT SUMMARY/ABSTRACT – Enrichment Program
The goal of the Enrichment Program is to promote scientific exchanges among Washington University Center
for Diabetes Translation Research (WU-CDTR) investigators with related research interests and enhance
interactions between diabetes investigators from other fields with relevant expertise. The program is guided by
our strategic vision in which a health equity lens is the foundation for transformative diabetes research
translated into action and impact. The Enrichment Program supports a national network of investigators and
community partners who are conducting rigorous diabetes translation research focused on our Center goal to
advance a scientific evidence base to inform rapid dissemination, implementation, and sustainability of
efficacious interventions for populations at risk for disparities in diabetes prevention and treatment. The
program has been critical in fostering diabetes research collaborations among investigators from different
disciplines and community partners, promoting development of early stage and under-represented minority
investigators, providing feedback to ongoing and planned research projects, and training future leaders in the
field. This is accomplished by a series of knowledge and skill building activities; transdisciplinary team science
activities to enhance interactions among investigators from diverse fields; and acting as a resource for diabetes
translation research.
The specific aims of the Enrichment Program are to: (1) provide regular seminars and educational
activities for WU-CDTR investigators and partners to stimulate intellectual exchange and collaboration to
address diabetes health equity; (2) provide learning opportunities to stimulate knowledge and skills in diabetes
translation research among WU-CDTR investigators and partners; (3) provide training and mentoring to early
stage and under-represented minority investigators in diabetes translation research; and (4) advance academic-
community partnerships and serve as a community resource for dissemination of diabetes translation research.
The Enrichment Program continues to contribute to an environment supporting and raising awareness of
innovative diabetes translation research across the T2 to T4 spectrum. The program has strong leadership,
regular and diverse input, an outstanding research environment, and is guided by regular evaluation which
further enhances learning opportunities for WU-CDTR investigators.